Effects of HIV SIV on unconventional T cells in immunity to M. tuberculosis in pre adolescents

Project Summary
Infection with Mycobacterium tuberculosis (Mtb) is a major global health problem in pediatric populations.
Children coinfected with HIV and Mtb have an increased risk of developing tuberculosis (TB), even if they are
on antiretroviral therapy. We know little about the specific immune defects caused by HIV that are responsible
for the increased susceptibility to Mtb, especially in children. As an airborne pathogen, Mtb first encounters
immune cells in the lung and the initial response to the infection can dictate whether the host controls the infection
or whether the bacteria replicate and spread, causing TB disease. Unconventional T cells, including CD1d-
restricted invariant Natural Killer (NK)T cells and Mucosal-Associated Invariant T (MAIT) cells, can detect and
destroy Mtb-infected cells and can act before adaptive immunity evolves. HIV impairs both cell types. In our
ongoing studies of HIV/Mtb coinfection, using adult macaques and SIV as an HIV surrogate, we found that
animals with chronic SIV infection are more susceptible to Mtb and that this is associated with elevated
expression of immune exhaustion markers (e.g. PD-1) on MAIT cells. This suggests that SIV-dependent
exhaustion of MAIT cells, and perhaps other unconventional T cells, may lower the resistance to Mtb. Here we
will use juvenile macaques to model HIV/Mtb coinfected children and determine whether a preexisting SIV
infection impairs MAIT and NKT cells. SIV-infected animals will be coinfected with Mtb and TB progression will
be quantitatively measured by several clinical, radiologic, and pathologic methods. We will correlate the
exhaustion phenotypes of MAIT and NKT cells with the severity of TB, comparing outcomes in SIV-positive vs
SIV-naïve juvenile macaques. To formally test whether SIV-dependent exhaustion of MAIT and NKT cells impairs
TB resistance, we will treat SIV-infected juvenile macaques with anti-PD-1 to reverse immune exhaustion of
MAIT and NKT cells. Following Mtb coinfection, we will compare cellular and humoral immune function as well
as TB severity in animals treated with anti-PD-1 to those treated with control antibody. We will also leverage an
existing pediatric HIV study in Yangon, Myanmar (R01MH108559) to characterize unconventional T cell
populations in pre-adolescents with and without HIV infection and HIV/Mtb coinfection. We will use PBMC to
determine the relationship between HIV and TB status with peripheral MAIT and NKT cell frequencies, immune
exhaustion status, and cellular function. Together, these studies will provide novel insights into the roles of MAIT
and NKT cells, as well as immune exhaustion, in HIV/Mtb coinfection of pre-adolescent children and may identify
targets for host-directed therapies aimed at improving the health outcomes of children living with HIV.

Public health relevance
Narrative Children living with HIV are much more susceptible to Mycobacterium tuberculosis, which causes tuberculosis, for reasons that are not well understood. We will use nonhuman primates to model HIV/M. tuberculosis coinfection of preadolescent children, determine how the virus affects a subset of innate immune cells, and test whether the ability of immunocompromised animals to fight TB is improved if we boost those cells. We will also examine these same cells in children from Myanmar who are infected with HIV, M. tuberculosis, or both.